Elucidating the molecular bases of species interactions in host-associated bacterial communities

Project Summary/Abstract
Microbial communities exert major impacts on animal biology and human health, and disruption of these
communities is associated with multiple disease states. To date, the field of microbiome research has been
dominated by surveys of microbial community compositions and by analyses correlating composition with host
phenotypes. But there have been few attempts to directly link the specific, causal processes that determine
colonization dynamics and success of host-associated bacteria, and how these interactions ultimately affect
hosts. The proposed research plan is motivated by the need for experimental systems to identify the
mechanisms that control the composition and consequences of host-associated bacterial communities. This
work focuses on two model systems that provide complementary approaches to examining host-associated
communities, and that offer new opportunities to identify the mechanisms underlying host colonization.
The honey bee and its specialized gut microbiota provides an exceptional model for multispecies gut
communities as it shares many features with the human gut microbiota. In both human and bee guts, a stable,
healthy community bestows “colonization resistance”, the exclusion of foreign microorganisms; in both
systems, disruption can result in dysbiosis and expansion of atypical communities, including enteric pathogens.
The human system is highly complex and not amenable to experiments, but, for the bee gut, we are able to
culture isolates of all component bacterial species and to introduce these to microbiota-free hosts to establish
defined communities. We have already developed genetic tools for experimental manipulation of the dominant
species. One set of experiments will identify the direct host-bacterial interactions that determine colonization
success or failure of particular strains that vary in ability to colonize honey bees. Existing results from a
mutagenesis screen indicate that features of the outer cell envelope play essential roles during host
colonization, and we will use new genetic tools to determine which of these factors are key to acceptance by
hosts. In addition to elucidating the mechanisms that enable specific bacterial strains to mono-colonize specific
hosts, a second set of experiments will investigate how the interactions between microbial strains, which range
from metabolic co-dependency to direct toxin-mediated antagonism, determine community membership.
The pea aphid and its endosymbionts provide an effective model for how intracellular bacterial associates
stably colonize host cells. Our newly devised techniques allow isolation, manipulation and inter-host transfer of
endosymbionts. To address how hosts control endosymbiont replication and persistence, we will perform
genomic comparisons, biochemical experiments to test effects of host-produced gene products on
endosymbiont cells, and physical and structural characterization of endosymbiont outer membrane proteins.
Through focus on experimental models that provide tractable examples of host-associated bacteria, this work
will illuminate the mechanisms that underlie ability of bacterial symbionts to colonize hosts.

Public health relevance
Project Narrative The establishment and persistence of specialized communities of bacteria are critical processes in animal and human development, and their disruption can lead to atypical or disease states. These processes are extremely complex in humans and other mammals, which harbor hundreds of interacting bacterial species. This project exploits simple, experimentally tractable insect models to elucidate how interactions of hosts and bacteria govern development of host-specialized bacteiral communities.